Characteristics and outcomes for hospitalized patients with methamphetamine and opioid co-use: Identifying opportunities for hospital-based addiction services tailored to co-use

PROJECT SUMMARY/ABSTRACT
Drug overdose deaths continue to rise in the United States, accounting for over 100,000 deaths in 2021 alone.
Methamphetamine and opioid co-use are largely fueling the most recent increase in mortality. In addition, co-
use associated hospital admissions increased more than five-fold between 2003 and 2015.
Previous research and hospital-based addiction services for substance use have focused on opioid use alone.
These addiction medicine services have increased rates of medication for opioid use disorder and improved
patient linkage to continuing outpatient treatment. As a result, hospital length of stay and readmission rates
have decreased. However, past research indicates individuals with co-use have different sociodemographic
and health profiles and are less likely to receive medication for opioid use disorder than individuals who use
opioids alone. There is limited evidence of how existing hospital-based addiction services effect patients who
co-use methamphetamine and opioids or how these services could be tailored to better treat hospitalized
patients with co-use.
The overall objective of this Kirschstein-NRSA F30 fellowship is to generate evidence that can guide the
eventual development, implementation, and evaluation of hospital addiction medicine treatment services
tailored to co-use. The specific aims of this proposal are: 1) to characterize patient demographics and
hospitalization characteristics associated with co-use from a nationally representative sample of inpatient
hospitalizations, 2) to quantify the risk of re-admission and mortality following hospital discharge, by substance
use profile, and whether differences vary by the receipt of hospital-based addiction services and 3) to identify
barriers and facilitators to providing hospital-based addiction services tailored for patients with co-use.
The proposed mixed methods project is based on a sequential explanatory approach. It includes training in
both quantitative (Aims 1 & 2) and qualitative (Aim 3) research methodologies. Through this work and a
thoughtfully designed training plan, the trainee will achieve the following goals: 1) develop health services
research expertise, 2) advance the substance use research field as it relates to polysubstance use, 3) integrate
research, clinical, and advocacy activities in the field of addiction medicine. This supports his long-term goal of
bridging health services research and clinical medicine to support patients with substance use disorders as a
physician-researcher.

Public health relevance
PROJECT NARRATIVE The substance use crisis in the United States increasingly involves the co-use of methamphetamine and opioids together. Given the unique sociodemographic characteristics and co-morbidities associated with co- use, existing hospital-based addiction services may not adequately serve patients who use both substances. This project will quantify patient demographics and outcomes following hospital discharge, by substance use profile, and identify facilitators and barriers to expanding hospital-based addiction services tailored to co-use in the inpatient setting, through a sequential explanatory mixed methods design.